Dynamic virus-driven remodeling of ER-mitochondria contacts

Viruses have evolved elegant strategies to manipulate host cell machinery and rewire core cellular pathways to
facilitate productive infection, including enhancing metabolic output and maintaining cell viability. To accomplish
this, viruses exert an extensive network of dynamic molecular interactions with cellular organelles. As the
functions of organelles are intimately associated with the regulation of their composition, shape, and localization,
the control of organelle structure-function relationships is at the core of clarifying the outcome of an infection.
While many examples of virus-induced organelle remodeling have been described, very little is understood about
how organelle structures engender specific functions. Our lab has characterized a previously unrecognized
aspect of viral infection, which is that human viruses globally control organelle remodeling by dramatically
rewiring inter- and intra-organelle membrane contact sites (MCS). Using a hybrid quantitative proteomics and
super resolution microscopy approach, we demonstrated exquisite reorganization in MCS networks engaged by
a broad range of human viruses, including both ancient (herpesviruses) and rapidly adapting (influenza and beta-
coronavirus) viruses. We further discovered that infection with the ubiquitous herpesvirus human
cytomegalovirus (HCMV) triggers a new specialized MCS structure, mitochondria-ER encapsulations that we
termed MENC. We determined that HCMV infection drives predominantly fission at the mitochondrial periphery,
and that the fragmented mitochondria enter MENCs and retain their bioenergetic activity. How the infection
induces MENC formation and the function of this newly reported structure remain unknown. We propose that
MENCs provide a unifying explanation for the longstanding paradox of how certain viruses such as HCMV
increase mitochondrial bioenergetic output, despite inducing mitochondrial fragmentation. Our central hypothesis
is that HCMV remodels inter- and intra-organelle connections, generating MENCs, which act to protect and
stabilize the bioenergetic capacity of fragmented mitochondria. Using a multidisciplinary approach that combines
molecular virology with cutting-edge approaches in quantitative proteomics, live super resolution microscopy,
ultrastructural electron microscopy, metabolomics, and lipidomics, in Aim 1, we will define the mechanisms
underlying the formation and function of MENCs during HCMV infection. In Aim 2, we will establish what
signaling cues from HCMV-induced three-way contacts among the ER, mitochondria, and lysosome stimulate
peripheral mitochondria fission and elevate bioenergetic respiration. In Aim 3, we will characterize the viral
factors that coordinate ER-mitochondria MCS rewiring. Collectively, our study will link newly discovered aspects
of virus-orchestrated MCS networking to new two-way and three-way organelle structure-function relationships
that underlie fundamental cellular mechanisms, including mitochondrial bioenergetics and autophagic turnover.
In doing so, our study will open research areas in how viruses exploit the functional capacities of remodeled
organelles for infection, which have broad implications for viral pathogenesis and metabolic disorders.

Public health relevance
PROJECT NARRATIVE For productive infection, human viruses control the function of organelles by rewiring the membrane contact sites (MCS) that facilitate dynamic organelle-organelle networks, which we uncovered occurs across viral infections. We further discovered a new, infection-induced mitochondria-ER encapsulation, which we propose addresses the paradox of how certain viruses promote cellular respiration despite inducing mitochondrial fragmentation. This proposal will establish how mitochondria-ER encapsulations inhibit host responses and facilitate metabolic reprogramming to meet the energetic needs of virion production, of which the molecular determinants have broad implications for viral pathogenesis and metabolic disorders.